22st Annual Rocky Mountain Virology Association Conference

Project Summary / Abstract
The Rocky Mountain Virology Association (RMVA) will hold its 22nd annual meeting September 30th-October
2nd, 2022. The meeting brings together regional and national investigators in virology and prion biology for a 3-
day retreat-style conference with extensive interaction and collaboration. The original meeting was organized by
investigators in Colorado and Wyoming interested in free and open exchange of scientific data and ideas in
virology in a venue that promotes collaboration among students, post-docs and faculty. Specifically, our annual
meeting at the Mountain Campus of Colorado State University encourages young scientists to present their
research and receive feedback from established scientists. The goals are promotion of scientific interactions
and training. A major benefit of participation has been the novel collaborations that arise between scientists in
different disciplines. Topics discussed include medical virology (vaccines, epidemiology, viral zoonoses),
arthropod-borne diseases (RNA viruses, RNA metabolism, viral vectors and vector biology), host defenses (viral
immunology and pathogenesis), prion biology, cancer biology and systems biology. Special sessions vaccine
development, pandemic viruses, virus discovery and the global impact of viral diseases have been common
features. The 2021 meeting had a retrospective on the COVID-19 pandemic with discussions on successful
approaches and establishment of systems for future challenges. The next meeting will feature discussions on
noroviruses, coronaviruses, innate immune evasion by viruses, virus control of host gene expression, zoonotic
transmission and science communication. The meeting offers excellent collaborative opportunities. Attendees
include scientists from Colorado State University, The University of Colorado, the University of Wyoming, the
University of Northern Colorado, the Centers for Disease Control (Fort Collins) and the Department of Agriculture
Animal and Plant Health Inspection Service, regional biotech companies, and universities in Iowa, Idaho,
Nebraska, Kansas, Montana, New Mexico and Utah. The RMVA was incorporated in 2010 as an educational
charity (501(c)(3)). Our volunteer board of directors is charged with encouraging student and junior faculty
involvement by minimizing costs as we encourage women and minorities to participate in all stages of program
presentation and development. Our attendance is limited to a maximum of 124 individuals, and the growth of the
meeting to capacity illustrates the desire of regional scientists to participate. Funds for this proposal are
requested to provide minority grants and childcare, reduced registration fees for graduate students, post-doctoral
fellows and early-stage investigators, and for travel and housing for seven invited speakers. Registration fees,
charitable contributions, and sponsorships cover the base costs for the meeting. The RMVA has been a source
of communication and collaboration in the Rocky Mountain region, with outreach across the nation, for twenty-
one years, and NIAID support has expanded interest in this meeting to national and international levels.

Public health relevance
Project Narrative The twenty second annual meeting of the Rocky Mountain Virology Association will continue scientific collaboration among virologists and prion biologists. Dedicated scientists from regional and national institutions, including universities and federal laboratories, with diverse expertise and a common interest in virology meet to promote multidisciplinary approaches, productive collaborations, and scientific inspiration. Their primary concern is the protection of people from infectious diseases.